Reward Valuation and Suicidal Behavior in High-Risk Adolescents

PROJECT SUMMARY
Suicide is a leading cause of death for adolescents worldwide, and rates have increased over the past decade.
Yet, we lack reliable predictors of suicidal behavior (SB) due in part to a need to consider a broader range of
risk processes and methods of assessment. There is a particularly critical and urgent need for research on
objective, prospective predictors of SB to identify youth at greatest risk and elucidate novel targets for
intervention. The goal of this study is to characterize alterations in RDoC’s Positive Valence Systems,
particularly neural processes involve in reward valuation, in a large, high-risk sample of adolescents in acute
psychiatric treatment for self-injurious thoughts and behaviors (SITBs) who will be followed for 6 months
following discharge—a period of high risk for SB. Our preliminary data and theories of SB highlight a key role
of reward valuation in that SB partly reflects a choice between immediate relief from emotional pain rather than
waiting for potential future rewards that come from continuing to live through difficult times. Consistent with
this, rigorous cross-sectional research has linked SB to greater discounting of the value of delayed monetary
rewards, and our preliminary data indicate enhanced neural responsiveness to immediate relative to delayed
rewards in youth with recent SB. Importantly, preferences for immediate rather than delayed reinforcers are
known to increase in times of high stress, and acute interpersonal stress is associated with elevated risk for SB
in adolescents, while social support tends to be protective. This multi-method, prospective study will test an
innovative conceptual model of SB by which youth with enhanced neural reactivity to immediate reinforcers
and blunted reactivity to delayed rewards are more likely to engage in SB, particularly in times of acute
interpersonal stress, and social support buffers effects of reward valuation on SB. We will recruit a
transdiagnostic sample of adolescents (ages 13-17 years; N=300) in acute psychiatric treatment for SITBs.
Participants will complete clinical assessments and behavioral and neural measures of reward valuation in the
hospital to capture a high-risk state and minimize participant burden. Following discharge, participants will
complete a brief daily survey of interpersonal stress, social support, and SITBs for 90 days. Finally, participants
will complete follow-up interviews of SITBs 6 months after discharge to test prospective predictors of SB. This
study will characterize patterns of reward valuation associated with SB histories in high-risk youth (Aim 1),
examine neural measures of reward valuation as prospective predictors of SB following hospital discharge
(Aim 2), and examine the interplay between neural reward valuation and interpersonal factors in the proximal
prediction of SB (Aim 3). This study directly addresses NIMH priorities and will be the first to examine neural
predictors of future SB in a large, high-risk sample of youth, extending RDoC-informed research on suicide risk
to the Positive Valence Systems domain. This research will lead to the identification of objective predictors of
SB risk and the development of more personalized, targeted interventions to prevent SB and suicide deaths.

Public health relevance
PROJECT NARRATIVE Adolescent suicide is a major public health crisis, with evidence of increasing rates in youth across the past decade, but we lack robust predictors of future suicidal behavior. We will examine neural measures of reward valuation as prospective predictors of suicidal behavior and responses to interpersonal stress in a large high- risk sample of adolescents followed for 6 months after acute psychiatric treatment. This study will advance understanding of pathways to suicidal behavior in adolescents and inform methods of identifying adolescents most in need of immediate intervention to prevent suicide.